Posttranslational regulation of macropinocytosis in pancreatic cancer

The majority of pancreatic ductal adenocarcinoma (PDAC) patients present with late-stage, metastatic disease
that is often resistant to therapeutics, resulting in the lowest survival rate of all major cancers. Metabolic rewiring
in response to oncogenic signals plays a critical role in PDAC cell survival, tumor growth, and metastasis. In
contrast to normal epithelial cells, these metabolic alterations make PDAC tumors dependent on glutamine for
survival, highlighting a unique metabolic vulnerability that can be therapeutically exploited. However, during times
of nutrient stress, PDAC cells can circumvent this vulnerability by engulfing extracellular fluids to replenish amino
acids, including glutamine, in a process called, macropinocytosis. Macropinocytosis occurs downstream of
oncogenic KRAS, a small GTPase that is almost universally mutated in PDAC patients. The inhibition of
macropinocytosis in vivo reduces PDAC tumor growth, underscoring the importance of this pathway to cancer
cell survival. However, there remain gaps in our knowledge regarding the signaling mechanisms that regulate
macropinocytosis and the contribution of macropinocytic signaling to aggressive cancer phenotypes. Protein
phosphatase 2A (PP2A) is a heterotrimeric complex that regulates a wide variety of cell signaling pathways,
including KRAS, and is commonly deregulated in human PDAC tumors. Recently, PP2A has been implicated as
an important regulator of macropinocytosis, but the mechanism by which this occurs is unknown. We have shown
that the genetic loss of the specific PP2A subunit, B56a, accelerates the formation of KRAS-driven pancreatic
lesions in an in vivo mouse model, implicating this subunit as a critical negative regulator of KRAS phenotypes
during PDAC progression. Here, we demonstrate that PP2A-B56a activation results in attenuated glutamine
signaling, a significant accumulation of macropinocytic vesicles, and cell death. Furthermore, the therapeutic
combination of PP2A activators and metabolic inhibitors leads to synergistic loss of PDAC tumor growth in vivo.
Based on these findings, we hypothesize that activation of PP2A-B56a sensitizes PDAC tumors to glutamine
antagonists by limiting metabolic plasticity through the blockade of macropinocytosis-dependent nutrient
acquisition. We will test this hypothesis in the following Specific Aims: 1) Identify the posttranslational
mechanisms by which PP2A-B56a regulates macropinosome-lysosome fusion, 2) Evaluate the impact of PP2A
activation on PDAC progression and macropinocytosis in vivo, and 3) Determine if PP2A activation increases
the efficacy of metabolic inhibitors, in vitro and in vivo. Successful completion of these studies will significantly
increase our knowledge of the posttranslational mechanisms that govern PDAC nutrient scavenging, providing
novel targets for drug discovery in a highly lethal cancer.

Public health relevance
Project Narrative The 5-year survival rate for pancreatic cancer patients is only 13%, indicating a critical need for an increased understanding of pancreatic cancer biology in order to identify new therapeutic targets. Metabolic plasticity has emerged as a critical mechanism for pancreatic cancer survival and therapeutic resistance. The major goal of this proposal is to determine the role of Protein Phosphatase 2A (PP2A) in the posttranslational regulation of nutrient scavenging pathways that contribute to PDAC survival and pancreatic cancer progression.